TYROBP/DAP12: a hub protein linking Alzheimer's disease, microglia, and gut microbiome.

ABSTRACT
Recent genetic and genomic approaches have converged on the role of microglia and inflammation in the
pathogenesis of Alzheimer’s disease (AD), potentially presenting novel opportunities for developing prophylaxis
and/or therapeutics against AD. In a multiscale gene network analysis, a group at the Icahn School of Medicine
at Mount Sinai highlighted TYROBP (aka DAP12) as a key driver gene in microglia activation and AD
pathogenesis. TYROBP is one of the first “hits” to emerge from the integrative multi-scale approach to sporadic
AD that forms the basis for the AMP-AD Accelerating Medicines Partnership in AD) Program. Our previous
studies in the APP/PS1 mouse model of AD pathology suggest that reduction of TYROBP at the mRNA or protein
level or inhibition of its activity could represent a potential therapeutic target for AD prevention or treatment by
repressing the expression of C1q and the induction of genes involved in the switch from homeostatic microglia
to disease-associated microglia. Gut microbiota have also been advanced as a modulator of microglial activity
and amyloid pathology. The overall goal of this study is to elucidate the role of TYROBP, the gut
microbiota, and their interaction on the regulation of brain physiology and AD. We propose two
complementary aims. First, we will identify the role and interaction of TYROBP and the gut microbiota on the
regulation of the brain transcriptome during physiological aging or during the onset and progression of amyloid
pathology. We will perform RNA sequencing and compare the transcriptomic profiles of WT and APP/PS1 mice
that are, respectively either WT or KO at the Tyrobp locus and that harbor either (a) normal gut flora in normal
abundance, (b) normal gut flora in reduced abundance or (c) pathological gut microbiota mimicking the flora
identified in mouse AD gut. Using 16S rRNA sequencing, we will identify changes in bacterial populations due
to gut microbiota-related maneuvers and modulation of TYROBP levels and will attempt to establish a causal
link between gut microbiota and the immune-Tyrobp regulated transcriptome. Second, we will define how
TYROBP level interacts with the gut microbiota, and how, in turn, these variables modulate AD phenotype and
microglia activation. We will perform a panel of behavioral and biochemical analyses in order to determine
whether modulation of levels and/or types of gut microbiota, TYROBP expression levels, or the combination of
both result in changes in microglial activity and AD pathogenesis.
The expected outcome of this study is to generate important novel experimental results that will elucidate the
role and the mechanisms of microbiota regulation of microglia activation and AD. This project will also generate
important data to determine whether the modulation of different types, levels, and ratios of gut bacteria could
modulate TYROBP activity and form the basis for clinical interventions aimed at slowing or preventing AD.

Public health relevance
NARRATIVE TYROBP is proposed as a key driver gene in microglial activation and Alzheimer’s disease (AD) pathogenesis. Our previous studies in a mouse model of brain amyloid pathology suggest that reduction of TYROBP at the mRNA or protein level or inhibition of its activity could represent a potential therapeutic target for AD. The hypothesis of this proposal is that TYROBP is a central determinant of how gut microbiota regulate microglia activity and AD progression.